Nonautonomous control of substrate morphogenesis by migrating cells

PROJECT SUMMARY/ABSTRACT
Collective cell migration is essential for the precise assembly of many tissues and organs during development,
and involves the interplay between multiple cell types. In all modes of collective migration, interactions with a
substrate modulate parameters such as cell polarity, directional movement, and even growth and
morphogenesis, with the extracellular matrix (ECM) serving as a scaffold for various signaling cues for
migratory cohorts. However, the extent to which migrating cells exert a reciprocal influence on their substrate
remains largely unknown. Drosophila caudal visceral mesoderm (CVM) cells undergo synchronous bilateral
collective migration along a trunk visceral mesoderm (TVM) substrate, which expresses fibroblast growth factor
(FGF) ligands that serve as chemoattractive, survival, and growth cues in order to drive proper CVM migration
and quality control to pattern the larval midgut musculature. However, CVM cells also display an
unprecedented level of influence on TVM development, with mismigrating CVM cells altering the directional
growth habit of TVM cells. The objective of this proposal is to understand the mechanistic basis for this
interaction between the CVM and TVM. We hypothesize that CVM cells nonautonomously modulate directional
growth in the TVM through positive regulation of the bone morphogenetic protein (BMP) signaling pathway. We
will employ a hybrid approach of established immunostaining and live imaging techniques to assay the
respective potential contributions of the BMP and FGF signaling pathways through tissue-specific rescue and
loss-of-function experiments. The rationale behind this approach is that understanding the mechanism
underlying interdependent tissue interactions will allow us to uncover novel ways in which precursor cells
interact with their extracellular environment during collective migration. The objective will be accomplished via
two specific aims: 1) Investigate the role of BMP signaling in CVM-dependent morphogenesis of the TVM, and
2) optimize in vivo live imaging to elucidate the nature of CVM-TVM interactions over the course of migration.
Our working hypothesis is that tissue-specific regulation of the BMP signaling repressor brinker (brk) by the
CVM is required to modulate TVM growth prior to myoblast fusion. As the majority of research has focused on
identifying and characterizing the signaling cues that tissue substrates use to modulate the behavior of
migrating cells, this work is innovative in that it investigates a dramatic, previously unknown example of how
migrating cells can in turn influence their substrate beyond modifying the extracellular matrix (ECM). This work
is significant in that it will contribute to a long-term research program for studying how multiple, complex
interactions between different tissues allow for proper patterning of an organ, which is of interest to cell,
developmental, and cancer biologists, as evidence for nonautonomous effects on tissue substrates has
implications for increasing our understanding of the mechanisms responsible for tumor metastases.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Collective cell migration is essential for a variety of processes including organ development and wound healing, and typically involves interaction with multiple tissue substrates. We are proposing the use of Drosophila caudal visceral mesoderm cells as a tractable model for how migratory collectives influence their extracellular environment. The extent to which migratory collectives influence their substrate remains largely unknown, and could provide insight into the nonautonomous morphogenetic events accompanying stereotyped organogenesis and invasive cell behavior, which has relevance to studies of metastatic cancer.